Virtual Care Consortium of Research (VC CORE) - COR-20-199

Background: Virtual care, now a mainstay in the Veterans Health Administration (VA), facilitates access to
critical clinical and social services for millions of Veterans. The term “virtual care” encompasses a suite of
technologies that include VA’s video visit platform, the MyHealtheVet patient portal, mobile apps, remote
monitoring devices and tools to collect patient-generated health data. Collectively, these technologies have
potential to enhance Veteran care and improve the workflow and workload of VA clinical teams. Yet for many
clinical scenarios, evidence regarding the effectiveness, quality, safety and cost implications of virtual care is
still in early stages. Understanding factors associated with access to and engagement with virtual care are
important for this to be an effective, equitable mode of care delivery within VA.
Significance: The Virtual Care Consortium of Research (VC CORE) was established in 2020 to address
pressing needs for virtual care evidence within VA. In close partnership with VA’s Office of Connected Care
and Digital Health Office, the VC CORE has grown to a diverse network of >380 investigators, clinicians and
staff. The VC CORE addresses VA Health Systems Research priority areas for 2026 and is responsive to
national legislation pertaining to VA virtual care, including the Cleland-Dole Act of 2022. Foundational VC
CORE accomplishments include an extensive portfolio review of VA virtual care projects, an online research
and implementation resource library, establishment of a cyberseminar series and monthly newsletter, a State-
of-the-Art conference to identify virtual care research priorities and facilitation of > 50 OCC-funded quality
improvement and evaluation projects.
Innovation and Impact: The VA has been an early innovator in virtual care, with routine use of video visit
capabilities, remote patient monitoring platforms, a web-based patient portal, and other technologies for
several decades. VC CORE innovations that support virtual care implementation and evaluation include
development of a comprehensive database of VA virtual care research, creation of a novel program to support
operations-funded virtual care evaluations, and contributions to two Congressionally-mandated reports.
Specific Aims: In the proposed VC CORE renewal, we will pursue four Impact Goals (IGs): In IG1, we will
strengthen the VC CORE network through targeted growth, enhanced collaboration and partnerships. In IG2,
we will foster rapid, rigorous and innovative research and QI activities focused on virtual care. In IG3, we will
support VA in its efforts to implement and disseminate virtual care across the enterprise. In IG4, we will
generate and synthesize evidence to advance VA practice and policy.
Methodology: In IG1, we will grow our network and build more connections between network members and
clinical operations partners, support requests for subject matter expertise from Office of Research and
Development (ORD) and other VA leaders and support the next generation of investigators through early-
career development opportunities. In IG2, we will foster virtual care research by updating VC CORE’s portfolio
review, working with existing ORD entities to develop and disseminate data measures relevant to virtual care
research and establishing a Veteran Engagement Panel. In IG3, we will identify innovative programs through
communication with the VC CORE network and support the dissemination of implementation resources using a
SharePoint repository. In IG4, we will track requests from operational and ORD partners (e.g., literature or
reporting requests), continue to orchestrate requests for applications for projects funded by OCC and other
partners, and synthesize evidence about the value and impact of project findings.
Next Steps/Implementation: The VC CORE has emerged as a critical supportive structure that facilitates high-
impact virtual care research and evaluation activities within VA. Renewal of the VC CORE will help sustain these
achievements and further enhance the impact of virtual care research to support VA as a learning health system.

Public health relevance
The Virtual Care Consortium of Research (VC CORE) monitors, coordinates and facilitates virtual care research and evaluation activities across the VA enterprise on behalf of Veterans, their families, caregivers and clinical team members. The VC CORE supports important priorities of VA’s Health Systems Research service, including: (1) Healthcare System Organization and Delivery, (2) Mental/Behavioral Health and (3) Healthcare and Clinical Management. Since its inception in 2020, the VC CORE has established a nationwide network of researchers that are advancing VA’s journey towards fully realizing the potential of its growing portfolio of virtual care technologies. Renewal of the VC CORE will enable expansions of ongoing virtual care evaluations, develop enterprise-wide data resources to enhance virtual care measurement and support the translation of virtual care research to policy and practice. This continuation of the VC CORE is an important step to sustain progress and further enhance the impact of VA virtual care research over the next 5 years.